Pharmacist-CHW Team to Improve Medication Adherence and Reduce Hypertension Disparities

Abstract
The U.S. faces profound racial and ethnic disparities in hypertension, which are exacerbated by disparities in
medication adherence. Yet few existing medication adherence interventions are tailored to address the specific
cultural beliefs of diverse populations who also face significant structural barriers to adherence associated with
poverty, access to care and food insecurity. The proposed Improving Medication Adherence with Pharmacist
and CHW Team (IMPaCT) intervention responds to the call for adherence interventions that are tailored for the
specific needs of minority racial-ethnic groups. IMPaCT is a practice-based randomized controlled trial (RCT)
to test the effectiveness of a comprehensive, individually- and culturally-tailored intervention for high-risk
patients with hypertension, polypharmacy and low adherence. IMPaCT leverages the specialized expertise of a
clinical pharmacist together with a community health worker (CHW) who will serve as cultural broker and
patient navigator to address individual, clinical, social-cultural, and structural barriers to adherence. This
comprehensive and tailored, coordinated care intervention aims to improve medication adherence and
hypertension outcomes among African-American, Latino and Vietnamese immigrant patients. The proposed
practice-based RCT is designed to meet the following specific aims:
Aim 1: Implement IMPaCT, an innovative, tailored adherence intervention delivered by a pharmacist and
CHW team.
Aim 2: Determine the short- and long-term effectiveness of IMPaCT by assessing pre- to post-intervention
changes in: a) medication adherence (proximal outcome) and blood pressure (BP, distal outcome), and b)
other comorbid health outcomes (e.g., HbA1c, BMI) using a randomized controlled trial.
Aim 3: Identify factors associated with IMPaCT effectiveness including: a) tailored intervention features, b)
medication beliefs, c) barriers to adherence, d) intervention dose, e) health literacy, and f) cultural group.
We will follow an intention-to-treat randomized design using a waitlist control with 450 African-American,
Latino, and Vietnamese patients with hypertension and low (<80%) medication adherence. Data collection via
pill count, self-report, the electronic health record, and clinical measures will assess medication adherence, BP
and other factors at baseline (pre-intervention) and at 4, 10, and 24 weeks post-intervention. IMPaCT is an
innovative coordinated care team intervention to improve medication adherence and blood pressure derived
from research findings that builds on existing clinical practice. Designed with an eye towards sustainability,
IMPaCT incorporates billable pharmacist and CHW services for patients with low medication adherence and
high burdens of chronic illness and preventable consequences. IMPaCT offers interprofessional team care with
comprehensive expertise and complementary skill sets that mitigate the silo effect of specialized medicine to
deliver primary care to diverse, high-risk populations experiencing disparities in hypertension.

Public health relevance
Project Narrative The proposed R01, Improving Medication Adherence with Pharmacist and Community Health Worker Team (IMPaCT) to Reduce Disparities in Hypertension, will test the effectiveness of an innovative, culturally-tailored, coordinated care intervention derived from previous research (RxHL Study, 1R01HL120907) and existing pilot medication therapy management program at the research site. Building on an ecosocial framework of chronic disease self-management, the IMPaCT intervention by pharmacist-community health worker team will identify and address individual, clinical, social-cultural and structural barriers to medication adherence among low- income minority patients with hypertension, polypharmacy use and nonadherence. To determine effectiveness, we will conduct a rigorous, intention-to-treat randomized controlled trial among African-American, Latino and Vietnamese patients at a community health center to create a practical solution to the adherence problem and provide a how-to framework for healthcare workforce to reduce health disparities in hypertension and prevent cardiovascular risks among the vulnerable population.